Core A Administrative Core

SUMMARY
The Administrative Core (Core A) is an essential core that will organize, coordinate, and oversee, and support
the three Projects, and the other two Cores of this PPG. The Core is co-led by George F. Murphy, MD, and
Markus H. Frank, MD, whose collaborative history, complementary expertise, and delegation of Core A
responsibilities are in keeping with the multi-PI infrastructure of this PPG. In addition to the institutional resources
and administrative support structures available to Drs. Murphy and Frank through BWH and BCH, respectively.
The overarching goals of the Core are summarized in the categories of i) communication and data sharing; ii)
oversight and guidance; and iii) administrative support, and may be briefly described as follows:
1) Implement and oversee a web-based mechanism for data sharing. This relates to the establishment and
maintenance of a web-based, secure site for data sharing consisting of three complementary layers of DropBox,
Harvard Dataverse and Basecamp, that permit secure access from any location or device with internet
capabilities. In addition, it recognizes the ongoing responsibility of Core A CL’s to regularly monitor data accrual
and overall PPG progress in a manner that data is rapidly and efficiently shared with the scientific community
through web-based technology and an ongoing commitment to publish appropriate findings in open-access
journals, or by utilizing public relations resources at the participating institutions for data sharing with the lay
public.
2) Monitor and maximize Project progress, inter-Project/Core synergies, and Core utilization. This includes the
creation of mutually-agreed upon milestones to be achieved among Projects and Cores, their centralized
monitoring, and maintenance of a continuous feedback loop involving Projects/Cores and Core A to maximize
project momentum, intercept and address any problems that may inhibit or delay progress, monitor aspects
related to reproducibility, and insure that appropriate deliverables are attained in a focused manner that insures
translational relevance and eventual clinical application. This aim is structured on regular (monthly) scheduled
interactions involving all Project and Core leads during which progress may be assessed and maximized.
3) Provide general administrative support for the PPG. This includes a) the scheduling of monthly meetings; b)
establishment and orchestration of periodic meetings with an External Advisory Board (EAB) to review progress
and assist in planning; c) conflict mediation and resolution; d) preparation of non-competitive renewal
applications and progress reports; e) budgetary management; f) coordination and facilitation of institutional
approvals; g) manuscript submission to PubMed Central; and management of new intellectual property created
from the grant, including preparation and filing of new invention disclosures to OTD).